ESTABLISHMENT OF A FOOD CODE TASK FORCE IN THE STATE OF MONTANA TO PROPOSE NEW ST

onaaDearmen o Healh...HmanServic-eos od...Consue afetySecton oodSfetyTskFocePoposedPln Mrch5, 2010 0-0-13,MCA ) DPHH wl cetea oodSfety TskFocemeetngthe MC andsumaizedbeow: ) DPHS wle tabishaFoodSafetyTskFoocaessis i hedevelomen o dinstatverulesortorevewanyproposedlegsatonreatedtot. hepovsons ) DPHH wl resen iaimsraiverlesadaylegislaio to e rophoseF oyo afety TskFoce fte a fnldaftiscop osed ) oodSfetyTskFocwiellbecomose o eualnumersofreresetaiveso he idsriesndrepesenttvesofstteandlocl govermet. Pocessfo deveopentofNewFoodRue piortoLegsatveProposl ) Thrtydysaregvenfo subissonofappictionsfo embeshpandcnodmaents sbseqet15aysforreviewadselecio madeby hedear mheenf.llwing citei wl be usedfo gadngappictonsvasubissonoftheAdpsprlicayio or i adgovermen reresetaives. a Tmecomtmentrequremen(etsleconerece, gropmeeigs,ec) b Exerieceworkigintheinusry, imeadsecfrcmlot es ) Commnicaioncaailiiestocositens ) OncetheFoodSfetyTaskFoceisdeveoped,thedeprtentwl pantosubita prpseddraftoftherevisedfodcde,Title 7,Chapter 1,Subchapter2. ) The TskFocewl decde,asa,goo uhemeeigdaes or eitercoferececalls,in- pesonmeetngs,o nothe approvedfor ofcomuncton. Meetngs wscle uble d nilheTas oFrceatemtstoreach cosess cocerigte roose Rle.

Public health relevance
DEPARTMENT OF PUBLIC HEALTH AND HUMAN SERVICES Brian Schweitzer Anna Whiting Sorrell GOVERNOR DIRECTOR STATE OF MONTANA www.dphhs.mt.gov PO BOX 4210 HELENA, MT 59604-4210 (406) 444-5622 FAX (406) 444-1970 FOOD PROTECTION TASK FORCES FUNDING: PAR-09-123 DPHHS will create a Food Safety Task Force as required in Montana Code Annotated: 50-50-103. Department authorized to adopt rules -- advisory council. (1) To protect public health, the department may adopt rules relating to the operation of establishments defined in 50-50-102, including coverage of food, personnel, food equipment and utensils, sanitary facilities and controls, construction and fixtures, and housekeeping. (2) (a) The department and local health authorities may not adopt rules prohibiting the sale of baked goods and preserves by nonprofit organizations or by persons at farmer's markets. (b) The department and local health authorities may not require that foods sold pursuant to this subsection (2) be prepared in certified or commercial kitchens. (3) (a) The department shall establish a food safety task force or advisory council to assist in the development of administrative rules or to review any proposed legislation related to the provisions of this chapter. (b) The task force or advisory council must be composed of equal numbers of representatives of the food establishments and representatives of state and local government. (c) The department shall present administrative rules and any legislation to be proposed by the department to the task force or advisory council prior to its proposal or introduction. When the department learns of proposed legislation related to the provisions of this chapter that has not been proposed by the department, the department shall provide copies of that legislation for review by the task force or advisory council and shall provide to the legislature any comments of the task force or advisory council. Melissa L. Tuemmler, RS Supervisor Food & Consumer Safety Section Montana Department of Public Health & Human Services P.O. Box 202951 Helena MT 59620-2951 Phone: (406) 444-5309 Fax: (406) 444-4135 Email: [email]